Eleventh Cooley's Anemia Symposium

Eleventh Cooley’s Anemia Symposium
PROJECT SUMMARY
Thalassemia syndromes affect at least two million people worldwide, and researchers believe that several
hundred million people may be “silent carriers” of a thalassemia trait, making it one of the most common single-
gene disorders in humans. The Eleventh Cooley's Anemia Symposium, which will be held The Cure in New
York City, NY, USA on October 17–20, 2022, represents the largest global gathering of thalassemia experts,
and provides one of the few instances each decade that the international research community, the
pharmaceutical industry, and funding agencies dedicated to fighting this blood disorder come together. This 3.5-
day conference will convene approximately 250 attendees, including scientific researchers working in the fields
of molecular and cellular biology, gene therapy, and stem cell development, as well as clinical specialists from
the fields of hematology, stem cell transplantation, maternal-fetal health, transfusion medicine, and pediatrics,
among others. The main objectives of this conference are to: (i) Provide a neutral forum for discussion of
existing clinical data, emerging strategies, and future directions for research and treatment of genetic
hemoglobinopathies, including Cooley’s Anemia; (ii) Attract/showcase early career and underrepresented
investigators (including women, ethnic/racial minorities, and persons with disabilities) via short talks, posters,
travel fellowships, and to provide opportunities to interact with senior investigators; (iii) Disseminate the
conference proceedings to the international community; and (iv) Foster collaboration between academia,
medicine, industry, and government to promote knowledge exchange and successful translation of research
into improved diagnostics and patient therapies for thalassemia and treatment-related organ damage. Cutting-
edge topics to be discussed during this symposium include globin gene regulation, iron metabolism,
management of clinical complications of thalassemia including a focus on alpha thalassemia, a major global
health problem, assessment and treatment of iron overload, results of ongoing clinical trials of gene therapy,
hematopoietic stem cell transplantation, and novel drugs, as well as innovative approaches to gene therapy.
The goals of this Symposium strongly support the mission of the National Heart, Lung, and Blood Institute and
National Institute of Diabetes and Digestive and Kidney Diseases in that the meeting will focus on multiple priority
areas of need: to advance hematology research, treatment and cure of disorders of hemoglobin, and to
improve safety and efficacy in blood transfusion medicine — including the diagnosis, management, and
prevention of iron overload and subsequent damage to the liver, heart, and endocrine system. Discussions
originating from the conference, and their dissemination via publication in Annals of the New York Academy of
Sciences, will have global impact by improving scientific understanding, advancing breakthrough
therapies, and ultimately reducing the healthcare burden of this family of genetic blood disorders.

Public health relevance
Eleventh Cooley’s Anemia Symposium PROJECT NARRATIVE Thalassemia syndromes are a group of genetic blood disorders that affect hemoglobin, the protein within red blood cells that carries oxygen from the lungs to the rest of the body and removes carbon dioxide waste; inherited mutations to these genes can cause chronic anemia, bony deformities, reduction in pediatric growth, and other complications. Children inheriting faulty globin genes from both parents, such as in thalassemia major/Cooley’s anemia, have severe anemia requiring monthly blood transfusions. While transfusions reduce the symptoms of thalassemia, over time, almost every patient experiences transfusion-induced iron overload and life-threatening organ damage to the liver, kidney, heart, and lungs, among others. Thus, thalassemia syndromes represent a significant burden to healthcare resources in the United States and globally, as patients require extensive medical care throughout their lives. The Eleventh Cooley's Anemia Symposium, which will be held at The Cure in New York City, NY, USA on October 17 – 20, 2022, is the preeminent forum for convening scientists, clinicians, industry, caregivers, policy makers, and patient support groups, on research and treatment for thalassemia syndromes. Since the first joint symposium of the New York Academy of Sciences and the Cooley’s Anemia Foundation in 1964, breakthrough research and early results of clinical trials shared at this conference (held approximately every 5 – 6 years) quickly become integrated by scientific researchers and healthcare providers alike; thus, expediting translation of new discoveries into possible medical treatments, and successful clinical trials into approved therapies. The 2022 conference will bring together approximately 250 participants from around the world to discuss basics science research and emerging therapies using cutting-edge tools and treatments which may have the potential to cure thalassemia. Publication of the conference proceedings in Annals of the New York Academy of Sciences will disseminate the information exchanged at the meeting to the global research and healthcare communities.